Administrative Core

PROJECT SUMMARY/ABSTRACT The Administrative Core (Core A) will provide coordination of scientific activities for the 3 projects and 2 cores. It will also facilitate daily operations and longer term planning for the individual and overall scientific program. The 2 specific aims of the Core are listed here. Specific Aim 1. To facilitate communication, data sharing, and organize meetings between project/core leaders and our internal advisory board. Specific Aim 2: To assist in sharing PPG generated research with the general scientific and lay community as well as within and among PPG investigators.

Public health relevance
Project Narrative: Not to be completed per guidelines.